National Health & Nutrition Examination Survey 2013-2014, Physical Activity, Sleep, and Strength Components

To provide support, to the National Center for Health Statistics (NCHS), for the Physical Activity, Sleep and Strength Components in the National Health and Nutrition Examination Survey (NHANES),